Investigating mechanisms of coordinating actinstructure across multiple levels oforder

PROJECT SUMMARY:
An organism's capacity to develop and grow is heavily dependent on its ability to organize various aspects of
structure, ranging from G-actin to F-actin, cross-linked filaments, F-actin networks, and multicellular
networks—in short, coordinate structure at multiple levels of order. Despite advances in characterizing proteins
that affect actin at different levels of the structural hierarchy, we have limited knowledge of how regulation of
actin is integrated across these hierarchical levels. Bitesize, the only Synaptotagmin-like protein in flies, is a
membrane-bound protein that has recently been demonstrated to also directly bundle filamentous actin;
preliminary data has further demonstrated that Bitesize promotes F-actin assembly. However, the mechanisms
driving these actin-organizing behaviors of Bitesize have not been determined; moreover, the manner in which
such mechanisms combine to produce a net effect in vivo is unknown. The long-term goal of this work is to
elucidate how mechanisms that control different hierarchical levels of actin organization are integrated to
facilitate morphogenesis. The overall objective of this proposal is to determine the mechanisms underlying
Bitesize's organization of actin and their combined effect on Drosophila embryo development. My rationale for
the proposed work is that Bitesize demonstrates direct interaction with actin, and therefore offers a unique
opportunity to study the direct regulation of actin's structural hierarchy at multiples levels through the probing of
a single protein. My hypothesis is that Bitesize integrates the regulation of actin assembly and actin bundling
via distinct domains along its length. My aims are to: 1) determine the mechanism used by Bitesize to bundle
actin, and 2) determine whether Bitesize separately regulates assembly and nucleation of actin. This approach
is innovative in its coupling of structure-function analysis of Bitesize’s interaction partners with the in vivo
study of btsz gene function in an animal tissue using precise gene edits. My proposed research is significant
because it will determine means of coordinating hierarchical structures of actin, and because it is expected to
demonstrate new mechanisms of regulating actin, such as stimulation of Dia via formin elongation effector
domains, that have not been demonstrated in animals in vivo. This research will be accompanied by training
in biochemistry as well as Drosophila embryology and genetics, which will take place in the Martin lab and
Schwartz lab in the Department of Biology and Cryo-EM Facility at MIT, as well as in the Goode lab at
Brandeis University. Together, this research and training will prepare me to establish an independent lab to
investigate fundamental questions related to the formation of functional, hierarchical structures in cells and
tissues.

Public health relevance
PROJECT NARRATIVE: Actin is a key component of the cellular cytoskeleton that enables cells and tissues to control their shape, and thus is essential for force generation (for example, during embryonic development) and migration (for example, during cancer extravasation), yet we lack the knowledge of how actin structures are coordinated across multiple levels of organization. This project aims to determine how the protein Bitesize, in the Drosophila fly model system, directly interacts with the actin protein to enable the individual actin molecule to assemble into filaments, and to organize these filaments into larger, more intricate structures. Thus, this research seeks to advance the NIH’s mission by establishing knowledge of how cells regulate the hierarchical actin structures that are fundamental to tissue development and disease.